SCH56592 IN CHRONIC ACTIVE PULMONARY OR NON MENINGEAL COCCI

Determine whether experimental drug SCH56592 is safe and tolerable for the treatment of chronic, active pulmonary or non-meningeal disseminated coccidioidomycosis.